Feasibility study of empagliflozin in patients with autosomal dominant polycystic kidney disease

PROJECT SUMMARY
Autosomal dominant polycystic kidney disease (ADPKD) is a common inherited disorder that leads to end-
stage kidney disease. Despite decades of research, tolvaptan is the only approved intervention in ADPKD.
However, tolvaptan does not target cardiovascular complications of ADPKD and is constrained by high cost
and side effects that limit adherence. Therefore, there is an urgent need for a well-tolerated alternative
intervention to slow ADPKD progression and improve vascular health. Sodium-glucose cotransporters-2
inhibitors (SGLT2i) have a track record of tolerability and safety in patients with proteinuric diabetic and non-
diabetic kidney disease. Trials of SGLT2i in these conditions have been extremely encouraging, and these
treatments are highly likely to become the standard of care for diabetic and non-diabetic kidney disease;
however, the mechanisms of action are not fully elucidated, and may be non-specific to disease etiology. The
potential benefit of SGLT2i has not been examined in patients with ADPKD, as major trials have excluded such
patients. There are also potential benefits of SGLT2i to ADPKD patients beyond slowing loss of kidney
function, as this class of drugs provide a cardiovascular mortality benefit for patients across the CKD spectrum.
Studies testing the effects of SGLT2i in animal models of PKD have yield conflicting results. Five weeks of
treatment with an SGLT1 and SLGT2 inhibitor phlorizon was shown to inhibit cystogenesis in the Han:SPRD
rat model of PKD. The mechanisms by which SGLT2i slows cystic renal disease progression may be related to
inhibition of cyst epithelial cell proliferation. SGLT2i have also antioxidant and anti-inflammatory actions, which
are important for reducing fibrosis and improving vascular health, both of which occur in early stages of
ADPKD. While many changes likely contribute to the development of arterial dysfunction in patients with
ADPKD, among those of greatest concern is the development of stiffening of large elastic arteries, typically
assessed by aortic pulse wave velocity (aPWV). We propose a pilot randomized clinical trial to determine the
safety and tolerability of empagliflozin in ADPKD patients. To achieve this, we will conduct a 12-month parallel-
group, randomized, double-blind, placebo-controlled trial in 50 ADPKD patients with an eGFR 30-90
mL/min/1.73m2. Secondary, exploratory endpoints will determine the effect of empagliflozin on kidney volume,
kidney function, aPWV, plasma copeptin levels, urinary kidney injury molecule-1 (KIM-1) and quality of life.
Specific Aim 1: To determine the feasibility, in terms of safety and tolerability, of prescribing empagliflozin 25
mg once a day in ADPKD patients at risk for progression with an eGFR of 30-90 mL/min/1.73m2.
Specific Aim 2: To derive preliminary estimates of the effect of empagliflozin compared to placebo on 12-
month change in a) total kidney volume by magnetic resonance imaging, b) eGFR, c) plasma copeptin levels
(a marker of vasopressin secretion), d) urinary KIM-1 (a marker of tubular injury), e) aPWV; and f) ADPKD-
specific health-related quality of life (HRQoL) as quantified by the ADPKD-Impact Scale.

Public health relevance
PROJECT NARRATIVE There is an urgent need for a well-tolerated intervention to slow autosomal dominant polycystic kidney disease (ADPKD) progression and improve vascular health and symptom burden. Sodium-glucose cotransporters-2 inhibitors (SGLT2i) have a track record of tolerability and safety in patients with proteinuric kidney diseases but have not previously been studied in patients with ADPKD. This pilot and feasibility randomized trial of the SGLT2i empagliflozin in patients with ADPKD at high risk of progression will test the safety and tolerability of this medication, and provide preliminary estimates of its efficacy on disease progression, vascular health, and symptoms, to support a subsequent definitive phase III clinical trial of the clinical efficacy of SGLT2i in ADPKD patients.